Engineering lipid nanoparticle platform for selective and enhanced delivery in vivo

Project Summary
The long-term goal of my independent research program is to develop robust LNP platforms for treating genetic
diseases and protein replacement therapies. Lipid nanoparticles (LNP) have emerged as a promising technology
for mRNA delivery without the drawbacks associated with viral delivery. Despite this progress, a major hurdle
remains the lack of efficient and selective delivery vehicles, as most mRNA targets are difficult to reach and
primarily accumulate in the liver. Despite progress in this field, these fundamental questions remain unanswered
- 1) How do LNPs interact with endogenous systems and get trafficked, and can we leverage these interactions
to redesign and improve delivery systems? 2) How does the incorporation of endogenous ligands change key
LNP properties such as encapsulation efficiency, endosomal escape, protein expression, and
immunomodulation responses? Addressing these critical questions is essential for developing more effective
next generation LNP systems that can function as advanced therapeutics and create a streamlined approach to
move these innovations from lab to clinical application. Over the next five years, my research program will seek
to bridge the knowledge gap regarding how surface decoration with endogenous ligands interacts with plasma
proteins and influences the physicochemical and biochemical properties of LNPs. To accomplish this, we will
explore three distinct avenues that will work together synergistically to improve the performance of LNPs in vivo.
First, we will develop LNP platforms with enhanced targeting properties by incorporating endogenous small
molecules and neutral lipids as a fifth component to modify LNP surface properties. We will assess how these
modifications impact biodistribution in vivo, with a primary focus on targeting the pancreas and immune system.
Next, we will gain a mechanistic understanding of the interaction between targeting LNPs and protein corona.
We will investigate how the physicochemical characteristics of nanoparticles influence protein corona formation
and interact with endogenous receptors that regulate trafficking to the target site. Identified proteins will be further
validated using their agonists as the fifth component. Finally, we aim to optimize LNP formulations by
incorporating endogenous small molecules as the fifth component that can stabilize ribosomal assembly, and
boost ribosome production, thereby increasing protein expression. We will examine how the physicochemical
properties of nanoparticles affect endosomal trafficking and contribute to enhanced protein expression.

Public health relevance
Project Narrative Lipid nanoparticles can deliver mRNA to different cell types, including lymphocytes, but they still lack effective systems for accessing diseased cells and tissues with high efficacy and selectivity in the extrahepatic space. Here, we propose to develop lipid nanoparticles with improved selectivity and delivery efficiency for in vivo applications, specifically targeting the pancreas and immune cells in the extrahepatic space.